Whole slide scanner for translational neuroscience research

PROJECT SUMMARY/ABSTRACT
Digital pathology has revolutionized clinical and research applications in the field of pathology and related
disciplines. In particular, the advent of whole slide imaging (WSI) has allowed rapid acquisition, high-level
comprehensive unbiased analysis, and convenient storage and transfer of histological data from entire glass
slides of tissue specimens. WSI is especially conducive to neuroscience research, promoting conventional
histological and advanced immunohistochemical and molecular analysis of brain samples. Since 2010, a heavily-
utilized WSI system in the Alafi Neuroimaging Laboratory core facility at Washington University School of
Medicine (WUSM) has helped advance translational neuroscience research in a variety of neurological and non-
neurological disorders. With increasing demands for Alafi WSI services among NIH-funded users exceeding our
current capacity and in conjunction with the planned opening of a new 600,000 square foot WUSM Neuroscience
building with over 125 neuroscience laboratories and approximately 1000 neuroscientists, this shared
instrumentation grant application proposes to acquire a new WSI system that will further facilitate and expand
cutting-edge translational neuroscience at WUSM. The proposed WSI system (Epredia Pannoramic 250 Flash
III) will be utilized by ten Major Users and eleven Minor Users performing translational neuroscience research in
animal models of multiple neurological disorders, including Alzheimer's disease, stroke, epilepsy, neurogenetic
disorders, neonatal hypoxia-ischemia, motor neuron disease, multiple sclerosis, spinal cord injury, pain, and
brain tumors. Funded by over 30 NIH grants, Major and Minor Users will account for at least 75% of accessible
user time, with the remaining time available for new users and other researchers within the Neuroscience building
and elsewhere on campus. As the WSI system can perform automated, unattended scanning acquisition for
some studies, we anticipate operation for close to 100 hours per week.
The proposed system will be housed in the Alafi Neuroimaging Laboratory, relocating to the new neuroscience
building in 2023, and be managed by the Hope Center for Neurological Disorders, an interdepartmental research
center administered within the Department of Neurology. The Hope Center will commit financial support and
resources for renovation of space and ongoing facility expenses, such as core personnel and service contracts,
through an existing recharge center and other funding sources. The principal investigator and experienced core
support staff will assist and train users in equipment use and data analysis. Data storage and management will
be supported by a WUSM Information Technology services group. An Advisory Committee, consisting of Major
Users and other faculty with administrative or scientific expertise related to imaging, will oversee the equipment
planning and utilization. Overall, a new WSI will greatly promote the next wave of advances in understanding the
pathophysiology of the most significant neurological diseases and developing novel targeted therapies for these
devastating disorders.

Public health relevance
PROJECT NARRATIVE Public Health Relevance Statement: Whole slide imaging (WSI) is an advanced digital technological method for acquiring, analyzing, and storing comprehensive pathological results and data for research. This grant proposes to obtain a WSI system that will be used by multiple teams of researchers at Washington University Medical School to advance neuroscience research in a variety of neurological disorders, including Alzheimer's disease, stroke, epilepsy, neurogenetic disorders, multiple sclerosis, brain tumors, headaches, and spinal cord injury. The work in this grant utilizing WSI should promote better understanding of the pathological mechanisms causing these neurological diseases and ultimately the development of novel, more effective treatments for these devastating disorders.